NEBRASKA'S MAINTENANCE OF THE ANIMAL FEED REGULATORY PROGRAM STANDARDS WITH PREVENTIVE CONTROL REGULATORY ACTIVITIES AND CAPACITY BUILDING

Project Summary/Abstract for PAR-20-132 Development and Maintenance of the Animal
Feed Regulatory Program Standards with Optional Coordinated Preventive Control
Regulatory Activities and Capacity Building (U18) Clinical Trial Not Allowed.
The Nebraska Department of Agriculture (NDA) and its Commercial Feed Program are
excited for the opportunity to continue its effort of maintaining the Animal Feed Regulatory
Program Standards in the State of Nebraska, and incorporating the Preventive Controls
Initiative into a state level equivalency. The State Program's goals in maintaining full
implementation of AFRPS is to maintain its animal food safety contract in good standing
with FDA throughout the period of the contract agreement; continue meeting all reporting
obligations of the cooperative agreement along with usage of the Improvement Plan from
Standard 9 to track and implement changes and improvements; maintain risk-based firm
inventory and enhance the criteria for determining risk. The State Program conducted a
preliminary statewide industry survey across different animal food manufacturers and
distributers to assess their readiness and knowledge of 21 CFR 507. The Preventive
Control Initiative funding will allow the State Program to hire a new staff member dedicated
to PC and CGMP education and outreach, which will be directed toward the lower and mid-
tier manufacturers and distributers as a result of the State Program survey. The outreach
and education plans include but are not limited to mailing information to firms, holding
regional workshops, and collaborating with outside educators. The State Program plans to
repeat its survey toward the end of the 5-year cooperative agreement to assess success of
the outreach plan. Along with outreach and education, the State Program will move towards
Phase 2 and Phase 3 audits as described in Field Management Directive (FMD)-76, by year
5 of the cooperative agreement. NDA and the Commercial Feed Program believe they will
make the most of this funding opportunity to build upon the progress already achieved
under AFRPS. With the addition of the PC Initiative funding, this opportunity will help NDA
meet their purpose of safeguarding human food and animal health, ensuring feed is safe,
unadulterated, and honestly prepared.

Public health relevance
Project Narrative for PAR-20-132: Development and Maintenance of the Animal Feed Regulatory Program Standards with Optional Coordinated Preventive Control Regulatory Activities and Capacity Building (U18) Clinical Trial Not Allowed. The Nebraska Department of Agriculture (NDA) is prepared to begin the Maintenance phase of AFRPS and the Preventive Controls Initiative. NDA has found that AFRPS has been of tremendous benefit, helping the program become more efficient and aiding in our mission of safeguarding human food and animal health by ensuring feed is safe, unadulterated, and honestly prepared. We anticipate the PC Initiative will continue that mission, allowing NDA to help feed firms ensure they are adhering to the rules set forth in 21 CFR 507, through outreach and education opportunities.